IntERact: Preventing Risky Firearm Behaviors Among Urban Youth Seeking Emergency Department Care

Firearms are the leading cause of death for U.S. youth. National organizations have highlighted the need for
prevention programs focused on decreasing interpersonal firearm violence. Urban EDs are an underutilized
setting for such programs, as they provide access to at-risk youth engaged in risky firearm behaviors (RFBs).
Intervening early with youth in this setting may decrease subsequent firearm violence and related
consequences. Despite the importance of this problem, evidence-based interventions to decrease RFBs are
lacking. Given our prior work showing that single session ED interventions (i.e., SafERteens) integrating
motivational interviewing (MI) and cognitive behavioral therapy (CBT) are efficacious reducing violence among
lower risk youth, the application of this behavioral therapy, expanded to address greater problem severity over
multiple sessions and enhanced by adding care management (CM), represents a potentially efficacious
approach for decreasing RFBs. Our pilot of this integrated approach was found to be feasible among high-risk
youth engaged in violence. Utilizing centralized remote therapy to address identified in-person therapy barriers
(e.g., transportation) and supporting the intervention with an APP may be a promising way of enhancing
session attendance, intervention dose, and engagement, while considering future implementation issues. This
proposal addresses Objective Two (Funding Option B) of the CDC NOFO as it focuses on collecting new
data on strategies to decrease firearm violence. We propose a 2-arm randomized control trial (RCT) enrolling
ED youth (age 16-24) reporting past 3-month firearm carriage and smartphone ownership, randomizing them
to either: (1) IntERact; or, (2) an enhanced usual care + assessment (EUC+A) condition where they will receive
a resource brochure and daily assessments. The IntERact condition will receive: (1) 6 remotely delivered
behavioral therapy sessions integrating MI, CBT, and CM; and, (2) an smartphone APP supporting the therapy
by facilitating therapist contact, conducting automated daily assessments, delivering between session tailored
MI/CBT content, delivering just-in-time GPS-triggered notifications upon entry into high-risk locations, and
aiding with CM resources. Specific aims are: (1) To conduct an RCT enrolling 400 eligible youth (200/group)
to examine IntERact efficacy; and, (2) To conduct a cost evaluation, comparing resource costs for intervention
delivery to costs for outcomes averted. As a secondary aim, we will examine mediators/moderators of
efficacy. Outcomes will be assessed at 3- and 6-months. Primary outcomes include: (1) risky firearm
behaviors (RFBs); (2) firearm carriage; and, (3) violence (i.e., aggression; victimization; consequences).
Secondary Outcomes include: (1) ED visits for violent injury (e.g., firearm injuries); (2) substance use; (3)
mental health symptoms (i.e., anxiety, depression, PTSD); and, (4) criminal justice involvement (i.e., arrests).
Given elevated rates of RFBs among socio-disadvantaged youth with disparities in access to services, the
proposed IntERact intervention, if found to be efficacious, has the potential for significant public health impact.

Public health relevance
PROJECT NARRATIVE Firearms are the leading cause of death for U.S. youth; 60% due to homicide. This study, conducted among youth (16-24 years old) seeking treatment in an urban emergency department (ED) who report past 3-month firearm carriage and smartphone ownership, aims to test a behavioral intervention consisting of 6 remotely delivered therapy sessions integrating motivational interviewing (MI), cognitive behavioral therapy (CBT), and care management (CM), supported by a smartphone APP that facilitates therapist contact, conducts automated daily assessments, delivers between session tailored therapy content, delivers just-in-time GPS- triggered notifications upon entry into high-risk locations, and aids with utilization of local resources. Given elevated rates of firearm violence among socio-disadvantaged youth with disparities in access to community services, the proposed intervention, if found to be efficacious, has the potential for significant public health impact.